2025 Genome Architecture in Cell Fate and Disease Gordon Research Conference and Gordon Research Seminar

Project Summary
The goals of this meeting are to cover the latest advances in chromatin structure and long-range gene regulation
in normal physiology, in disease and in response to environmental insults, to bring together the international 4D-
Nucleome community, to create a forum of learning and discussion, and to inspire future developments and
collaborations. We propose an interdisciplinary conference to cover the 4D Nucleome theme across scales of
genome regulation, from local chromatin processes involving transcription factors and epigenetic modulators, to
the higher-order mechanisms of three-dimensional chromosome folding, and the functional and structural
organization of the genome within the cell nucleus. We will especially highlight research that investigates 3D
genome architecture across broad disease topics, including cancer, neurodevelopment and neurodegeneration,
muscle and hematological pathologies. Past decades have witnessed rapid conceptual and technological
progress in deciphering the fundamental mechanisms that regulate 3-dimensional structure of the human
genome, including targeted actions such as the NIH Common Funds 4D-Nucleome program. The meeting will
address the latest challenges to determine the role of genome structure in development and disease, its interplay
with epigenetic and chromatin regulation mechanisms. We aim to foster knowledge transfer between 4D
Nucleome and disease modelling experts, stimulate interdisciplinary discussions, identify knowledge bottlenecks
and collaborative opportunities. To reveal the complex mechanisms of gene regulation in time and space, major
ongoing efforts aim to decode the rich genetic and epigenetic information stored in the genome sequence, to
model it using universal physics concepts, and to derive predictive models. We will also highlight innovations in
the engineering of genome topology, through optogenetics or other tools that can alter the molecular
reorganization of DNA, RNA or proteins in the nucleus. We will highlight exciting advances in chromatin structure
analysis with multimodality, such as parallel detection of chromatin accessibility and gene expression, with
single-cell resolution and tissue spatial information, with special interest in human-relevant applications. The 4D-
Nucleome field is poised to develop actionable strategies for innovative disease diagnosis, prognosis and
therapy, and to contribute to precision medicine and to more efficient and impactful strategies for disease
inception and therapy. The 2025 GRC/GRS meetings on “Genome Architecture on Cell Fate and Diseases:
Probing and Controlling Gene Regulation in Space and Time” will foster exchanges of exciting concepts, new
technologies, and interdisciplinary collaborations. We will provide an interactive, diverse, and inclusive forum for
trainees and new investigators across interdisciplinary topics, highlighting their research through short talks,
poster previews and poster sessions, while promoting networking opportunities with senior expert.

Public health relevance
Project Narrative Understanding variations in genome sequence and how they relate with human disease remain a major challenge in genome research. The three-dimensional structure of the human genome plays central roles in cellular and organismal health, and is disturbed in many diseases, such as developmental defects, neurodegeneration and cancer. The conference’s main objective is to promote knowledge exchange, discussion and inspire collaboration among junior and senior scientists working in chromatin architecture, gene regulation, and diverse aspects and challenges in applying basic knowledge to actionable interventions to improve human health.